Developing a Comorbidity Index for Health-related Quality of Life Studies

[unreadable] DESCRIPTION (provided by applicant): The overall goal of this study is to derive a co-morbidity index that includes diseases that have the greatest association with health-related quality of life (HRQL) as measured by the SF-12, a general HRQL instrument, in the MEPS dataset. The secondary goal is to validate the new index using data with a unique set of patients with the same measures. Another secondary goal is to compare the performance of the new HRQL co-morbidity index with the mortality-based co-morbidity index, the Charlson Index. This study will use the 2003 full year dataset of the MEPS to develop the HRQL-specific co-morbidity index using the SF-12 PCS (physical-related HRQL) and MCS (mental health related HRQL) as the HRQL dependent variable. The index will be validated using the 2005 full-year dataset within the MEPS. Further validation testing of the new index will be conducted using the same procedures using the Charlson Co-morbidity index. The initial step in index development will be to identify respondents who themselves completed the SF-12 and who were 18 years of age or older. Using a unique respondent identifier variable in MEPS, the Clinical Classification Codes (CCCs) within the MEPS HC-078 Conditions File that meet the following criteria will be merged with the Consolidated Full Year data file. CCCs that will be excluded include conditions that are gender specific, acute trauma, dementia or mental retardation, and administrative codes. A relatively new statistical model selection technique will be used to search through the model space for important models and predictors, not just singling out one specific model. These include the LASSO (Least absolute shrinkage and selection operator) and CART (classification and regression trees) techniques. These techniques will be applied separately for the SF-12 PCS and MCS. Once the top prediction models are identified for the SF-12 PCS and MCS HRQL scores, we will assess them via several selection criteria such as adjusted R-square, Mallow's Cp, Akaike Information Criteria (AIC), and Bayes Information Criteria (BIC) to arrive at the final selected model. [unreadable] [unreadable] [unreadable] [unreadable]

Public health relevance
Narrative Commonly used comorbidity indices were derived to predict mortality and therefore include a defined set of illnesses that have resulted in a combination that has the highest and most consistent predictive power for mortality. It stands to reason that the illnesses that lead to death may not necessarily be the same as those that will have the greatest influence on health-related quality of life (HRQL) or functional status. Highly symptomatic illnesses such as allergic rhinitis and osteoarthritis are not by themselves usually associated with mortality but can greatly impair HRQL. Yet, most research up to today uses the common mortality-derived comorbidity indexes to control for concurrent illness even when the primary outcome is HRQL. This study will attempt to derive and validate a more meaningful comorbidity index that may be used to control for the influence of comorbid conditions when analyzing health-related quality of life data in population-based studies. Secondly, a comparison of the predictive ability of previously published indices and the HRQL- specific index will be conducted. Researchers and analysts who use the MEPS dataset for studies where health-related quality of life is the dependent variable should find this work valuable as will any other researcher wishing to control for the effect of comorbidity on HRQL. The ability to use a comorbidity index that has demonstrated validity will allow users of MEPS dataset to rest assured they are using the best measure available.